Multi-Stakeholder Determinants of Medicare Diabetes Prevention Program Implementation and Participation

PROJECT SUMMARY/ABSTRACT
Nearly half of US adults age ≥ 65 (> 24 million) have prediabetes, which is often a precursor to type 2 diabetes
mellitus (T2DM) and associated cardiovascular (CV) diseases and mortality. To address this public health
burden, the Centers for Medicare and Medicaid Services enacted coverage of the Medicare Diabetes
Prevention Program (MDPP) in 2018. Based on the National Diabetes Prevention Program (NDPP), the MDPP
is an evidence-based (EB) lifestyle intervention that holds great promise, but is often unavailable and greatly
underutilized. Reasons for lack of access and use remain unidentified, leaving a critical need to determine the
individual, organizational, and contextual factors among program suppliers, older adults, and healthcare
providers that are affecting MDPP availability and use. The objective for this R15 REAP application is to
determine the diverse factors, processes, facilitators, and barriers affecting MDPP implementation and use,
while providing an opportunity to stimulate research at Duquesne University. Without identifying these factors,
implementation strategies to reduce barriers and promote facilitators of the MDPP cannot be readily enacted.
We will pursue three specific aims using the Consolidated Framework for Implementation Research (CFIR) to
guide a multi-level, convergent mixed methods investigation of the MDPP. Aim 1: Identify perceived facilitators
and barriers to implementation and use of the MDPP in a national sample of program suppliers and older
adults. We will conduct ~15 web-based or phone interviews with each stakeholder group: MDPP suppliers,
NDPP suppliers, MDPP participants, and eligible non-participants. We will also administer an established
survey to 64 MDPP and 64 NDPP suppliers to assess the Inner Setting of the CFIR. Aim 2: Determine current
practices and recruitment strategies MDPP suppliers use to raise awareness of the MDPP and enroll older
adults. We will first administer the Program Adoption and Implementation Strategies elements of a web-based
survey to a national sample of 80 MDPP suppliers, and identify the strategies yielding the highest enrollment of
older adults. Aim 3: Determine the individual and organizational factors promoting or inhibiting referral of
eligible older adults to the MDPP among a national sample of healthcare providers. We will administer a web-
based version of the Healthcare Provider Prediabetes Survey to 200 physicians and advanced practice
providers; we will also interview a subsample of providers (~30) to gather in-depth qualitative data. Data from
Aims 1, 2, and 3 will be triangulated, or integrated, using the CFIR as the guiding framework. Results of the
proposed research are essential to inform the development of implementation interventions for multiple
stakeholder groups, to scale the MDPP to a level that meaningfully reduces the burden of T2DM and CV
disease. The MDPP is the first Medicare-covered disease prevention program, but coverage is not yet
permanent. Ensuring success of the MDPP will preserve this benefit for millions of at-risk older adults and help
drive payor coverage for other prevention programs in the future. Our team’s long-term goal is to reduce the
burden of lifestyle-driven CV disease by facilitating implementation of EB interventions.

Public health relevance
PROJECT NARRATIVE Promoting lifestyle interventions for older adults with prediabes can help to reduce the disease and disability burden of type 2 diabetes mellitus (T2DM) and cardiovascular diseases in the US. The proposed study will examine factors associated with lack of access and use of the Medicare Diabetes Prevention Program (MDPP) among four key stakeholder groups through survey data and qualitative interviews. Once such factors have been identified, we can inform future strategies to promote the wide-scale implementation and utilization of the MDPP and decrease the ~$74 billion in annual medical costs attributable to T2DM for the Centers for Medicare and Medicaid Services.